Project-002

Asthma can manifest with varying levels of severity. Whereas the acute phase of mild and moderate asthma
is characterized largely by rapid infiltration of a number of immune cell types within the lungs, such as T
lymphocytes, eosinophils, and mast cells, severe asthma has additional inflammatory and remodeling features
that are thought to strongly contribute to decline in lung function. These include smooth muscle changes
(hypertrophy, hyperplasia and contractile hyperresponsiveness), and subepithelial fibrosis. Fibrosis is due to
deposition of extracellular matrix proteins such as collagen, fibronectin, fibrillin, and laminin, thought to be
produced largely by differentiating fibroblasts, but which might also be products of smooth muscle cells.
Fibroblasts can additionally be induced to express α-smooth muscle actin and other contractile proteins and
may further contribute to increased rigidity of the airways together with the mature smooth muscle cells that
line the bronchioles. The changes in activity of lung fibroblasts and smooth muscle cells linked to severe
asthma are not fully understood, but are thought to be driven by factors derived from immune cells, of which
IL-13 and IL-17 have been proposed to be key contributors. However, the true diversity and range of activities
of fibroblasts and smooth muscle cells in severe asthmatics is not known nor how they differ from those in the
lungs of mild asthmatics. Recent data are finding that multiple phenotypes of structural cells are seen in the
tissues of patients with chronic immune diseases, such as ulcerative colitis, rheumatoid arthritis, systemic
sclerosis, and atopic dermatitis, suggesting that cooperative and synergistic effects of several inflammatory
factors might lead to these alternate pathogenic phenotypes that are important for severe disease. In this
regard, we have found, in animal models of severe asthma, that two members of the tumor necrosis factor
(TNF) superfamily, LIGHT (TNFSF14) interacting with its two receptors HVEM (TNFRSF14) and LTβR
(TNFRSF3), and TL1A (TNFSF15) interacting with its receptor DR3 (TNFRSF25), are central mediators and
drivers of the fibrotic and remodeling activity in the lungs resulting from chronic exposure to allergen.
Furthermore, the receptors for LIGHT and TL1A are expressed on human lung fibroblasts and human airway
smooth muscle cells, and both cytokines have strong activity in modulating inflammatory or contractile proteins
in these cells. This proposal will pursue the hypothesis that both LIGHT and TL1A are new mediators of
human airway remodeling in severe asthma and that these factors cooperate together, and with IL-13 and IL-17, to drive distinct pathogenic phenotypes in lung fibroblasts and smooth muscle cells that are associated
with severe asthma. The treatment options for asthmatics are currently limited. Understanding the functional
response that is elicited from the signals delivered by LIGHT and TL1A to human airway fibroblasts and
smooth muscle cells, and how these integrate with those from more classical cytokines such as IL-13 and IL-17, might lead to new and novel therapies for severe asthma.